ENZYME REPLACEMENT THERAPY IN DISORDERS THAT AFFECT THE CENTRAL NERVOUS SYSTEM

Because enzyme replacement therapy is so effective for patients with Type 1 (non-neuronpathic) Gaucher disease, we have performed investigations to try to deliver the required glucocerebrosidase to neurons in the central nervous system in order to treat patients with the neuronpathic forms of this disorder. We found that mannose-terminal glucocerebrosidase is stable within the substance of the brain following convection-enhanced intracerebral injection. Moreover, the enzyme migrates from the site of injection toward the cortex where neurons containing stored glucocerebroside occur. We have discovered that mannose-terminal glucocerebrosidase is taken up by cultured LAN-2 and other differentiated neurons in tissue culture, but this uptake is different from that mediated by the mannose lectin on the plasma cell membrane of macrophages. This receptor is also present on cortical neurons. We propose to exploit it to deliver glucocerebrosidase and other supplemental enzymes to treat various neurometabolic disorders.